2022 In Vivo Ultrasound Imaging Gordon Research Conference

PROJECT SUMMARY
Ultrasound is a ubiquitous clinical imaging modality, which is supported by a dynamic and scholarly research
community. There is currently no conference or professional meeting dedicated specifically to basic science
ultrasound research with the goal towards improving diagnostic ultrasound. The goal of the proposed Gordon
Research Conference (GRC) is to provide an intimate forum for scientific exchange among scientists and
researchers whose primary area of research is the development of novel diagnostic ultrasound techniques and
approaches. While diagnostic ultrasound has been around for multiple decades, the amount of innovation in
recent years has been immense. Ultrasound has evolved in recent years with the advent of ultrafast imaging,
super resolution imaging, photoacoustic imaging, artificial intelligence (AI) in imaging, molecular imaging, novel
contrast imaging, shear wave imaging, whole body imaging with tomography and quantitative ultrasound
techniques. These innovations are indicative of a vibrant and active research community. Therefore, it is vital
that this community provide an avenue that allows deeper discussion about the future and direction of in vivo
ultrasound imaging and provides engagement of researchers spanning from senior to new and young
investigators.
The inaugural Gordon Research Conference (GRC) on In Vivo Ultrasound Imaging has the goal of providing this
avenue for engaging the basic science, ultrasound research community. Ultimately, the success of this
conference will result in a biennial meeting to bring research professionals in the area of ultrasound imaging
together to address the latest trends and needs in diagnostic ultrasound. The main goals of the GRC are:
1. to provide an avenue to discuss the latest ground-breaking technologies in diagnostic ultrasound;
2. to stimulate cross-pollination and validation of different approaches for ultrasound imaging;
3. to identify what the needs are for the continuing development of novel ultrasound imaging technologies
and where new methods and approaches can be implemented;
4. to promote the work of new and young investigators.
The scientific topics of the GRC are focused on ultrasonic imaging and highlight the latest advancements in
diagnostic ultrasound, including ultrasound applications in therapy.

Public health relevance
PROJECT NARRATIVE There is currently no conference or professional meeting dedicated specifically to basic science ultrasound research with the goal towards improving diagnostic ultrasound. The goal of the proposed Gordon Research Conference (GRC) is to provide an intimate forum for scientific exchange among scientists and researchers whose primary area of research is the development of novel diagnostic ultrasound techniques and approaches. The scientific topics of the GRC are focused on ultrasonic imaging and highlight the latest advancements in diagnostic ultrasound.